PRODUCTION ASSISTANCE FOR CELLULAR THERAPIES (PACT)- CELL PROCESSING FACILITIES CELL MANUFACTURING AND PROCESS DEVELOPMENT SERVICES FOR PCT0025-01: FVIII TCR-ENGINEERED TREG CELL PRODUCT

No provided in proposal